Montana Occupational Health and Safety Surveillance Program

Montana Department of Labor and Industry
Montana Occupational Health & Safety Surveillance (MOHSS)
PAR-20-312
Project Summary
The Montana Occupational Health and Safety Surveillance (MOHSS) program works to accomplish three
main goals in order bridge the gap between occupational health surveillance and prevention and safety
activities. MOHSS accomplishes this through three primary activities that all together can provide
valuable information and lead to occupational health improvement across the state. Expected outputs
of the program include reports, publications, presentations, award, policies, and legislation that will lead
to the outcomes of reduced workplace injuries, illness, and fatalities.
The program collects, reports, and analyzes the Occupational Health Indicators as a baseline for
occupational health surveillance. The indicators collected on an annual basis allow for an analysis of
trends in occupational health. They are used to monitor Montana’s occupational safety and health
landscape, reveal areas in need of more in-depth surveillance, and guide prevention efforts.
MOHSS also uses interagency collaborations to improve the quantity and quality of occupational health
data collected and used for surveillance. MOHSS works to improve access to and quality of existing
systems as well as explore new data sources. In order to accomplish this, MOHSS collaborates with other
agencies and bureaus within Montana to take advantage of the large variety of surveillance systems
already in place. These include the Montana Department of Public Health and Human Services, Montana
Department of Transportation, Montana Department of Environmental Quality, Montana university
system, and other outside organizations. The collaborations allow for research on emerging issues such
as COVID-19 and new occupational safety and health topics like Total Worker Health.
Finally, MOHSS creates and maintains active communication with stakeholders in occupational safety
and health to provide avenues through which information from MOHSS research can reach agencies
who are able to act on the findings. Findings from MOHSS guide interventions and preventative policy
targeting occupational health and safety hazards most efficiently. These relationships also provide
external guidance to MOHSS and provide council on aspects of occupational health of particular
importance or concern.

Public health relevance
Montana Department of Labor and Industry Montana Occupational Health & Safety Surveillance (MOHSS) PAR-20-312 Project Narrative Montana consistently has one of the highest incidence rates of occupational injuries and illnesses in the country. The Montana Occupational Health and Safety Surveillance (MOHSS) program allows for closer inspection of the causes of these high rates through the use of public health surveillance. Findings from the program are communicated to stakeholders to allow for improvements to be made.